Path C Maintaining the Produce Safety Program at VDACS under Path C to Enhance Produce Safety and Achieve High Rates of Compliance with the FDA's Produce Safety Rule.

PROJECT SUMMARY
Project Title: Maintaining the Produce Safety Program at VDACS under Path C to Enhance Produce Safety and
Achieve High Rates of Compliance with the FDA’s Produce Safety Rule.
Project Description: To maintain a produce safety regulatory program in Virginia to address the growing, packing,
holding and dissemination of produce grown on farms and achieve high rates of compliance with the FDA’s
Produce Safety Rule. This project will be a collaborative effort between FDA, the Virginia Department of
Agriculture and Consumer Services (VDACS) and the Virginia Polytechnic Institute and State University.
The VDACS Produce Safety Program will follow Path C of the cooperative agreement. As such, we also intend to
conduct sprout inspections under Subpart M of the Produce Safety Rule. The VDACS’ inspection and enforcement
authority is confirmed by state law that adopts 21 CFR Part 112 in its entirety.
(http://www.vdacs.virginia.gov/pdf/producesfty-VAlaw.pdf)
Project Goals: This project will follow the project plan for alignment of VDACS’ regulatory program and activities
with FDA’s Produce Safety Rule. Goals include conforming to the required program objectives (#1 through #7) in
the cooperative agreement targeted towards farm level entities that grow, harvest, pack and hold produce for
human consumption. The main goal of the project is to achieve high rates of compliance with the FDA’s Produce
Safety Rule that will encourage the safe production of fruits and vegetables, promote understanding and minimize
the risk of serious adverse health consequences or death from consumption of contaminated Virginia grown
produce as well as to ensure the further integration into a Nationally Integrated Food Safety System (IFSS).
Expected Outcomes: We believe that the partnerships and plans that will emerge from this project will create a
federal-state relationship that will leverage the existing expertise, knowledge and resources of the Virginia
Department of Agriculture and Consumer Services and the Virginia Polytechnic Institute and State University that
will result in consistent and successful regulatory farm inspections.
Budget: $925,000 per year, totaling $4,625,000 for the five-year grant period.

Public health relevance
PROJECT NARRATIVE The Virginia Department of Agriculture and Consumer Services (VDACS) project entitled Maintaining the Produce Safety Program at VDACS under Path C to Enhance Produce Safety and Achieve High Rates of Compliance with the FDA’s Produce Safety Rule is intended to enhance and maintain the current produce safety regulatory program in Virginia to address the growing, packing, holding and dissemination of produce grown on farms and achieve high rates of compliance with the FDA’s Produce Safety Rule. The VDACS Produce Safety Program will utilize federal funding to enhance or establish the following program objectives as identified in the cooperative agreement: • Objective 1 – Program Documentation: Create an Assessment document that will provide complete jurisdictional information related to each item under Produce Landscape, Produce Program Resources, and Produce-Related Response. Create a Project Plan that will document plans, progress, accomplishments, and setbacks in achieving each program objective. • Objective 2 – Program Administration: Establish the foundational resources, including, but not limited to, personnel, supplies, training, authority, and agreements, needed to fulfill the project plan. • Objective 3 – Education, Outreach and Technical Assistance: Provide opportunities for education, outreach, and technical assistance on the Produce Safety Rule and Virginia’s produce regulatory program to produce farms, prioritizing covered farms. • Objective 4 – Farm Inventory: Establish a complete and accurate inventory of produce farms, that captures at least the minimum required data elements, which can be used to implement corresponding objectives. • Objective 5 – Inspection Program: Conduct produce safety rule inspections that focus on quality and national consistency. Establish an annual inspection work plan that utilizes inspection frequency and risk-based prioritization. • Objective 6 – Compliance and Enforcement Program: Establish a compliance and enforcement regulatory program focused on quality and national consistency that utilizes compliance and enforcement action(s) that will result in the greatest protection of public health. • Objective 7 – Produce Related Event Response Planning and Implementation: Fully integrate with the Virginia Rapid Response Team to identify, coordinate, and implement produce related response activities that benefit public health outcomes. Develop specific mechanisms to coordinate with other local, state, territory, and federal agencies for produce safety activities where gaps may currently exist. Together, these seven objectives will further enhance the current produce safety regulatory program in Virginia so that high rates of compliance with the FDA’s Produce Safety Rule will be achieved. Additionally, they will encourage the safe production of fruits and vegetables, promote understanding and minimize the risk of serious adverse health consequences or death from consumption of contaminated Virginia grown produce as well as to ensure the further integration into a Nationally Integrated Food Safety System (IFSS). It is anticipated that through education and training along with enforcement and compliance of the FDA Produce Safety Rule, there will be less foodborne illness outbreaks nationwide traced back to raw produce grown in the Commonwealth of Virginia and less illnesses and deaths of Virginia residents consuming locally grown produce. Future federal funding and the actuality of FSMA are essential to the existence of the VDACS Produce Safety Program.